TRANSPORT II

ABSTRACT
The renewal application Translational Program of Health Disparities Research Training (TRANSPORT II) builds
on the successful research training programs established at SUNY Downstate Health Sciences University
(Downstate). Downstate is the only health sciences university in Brooklyn, the largest borough in New York City
with a population of approximately 2.6 million people and is located in a federally designated medically
underserved area. There is a dire need for scientists who can conduct rigorously designed research that informs
the development of sustainable solutions and advances equity. Over the past 5 years, our team implemented
diversity-focused research training programs that reached 109 students and faculty. The mission of renewal
TRANSPORT II is to maximize these successes by recruiting and training a diverse research workforce and
developing strategic partnerships with key community stakeholders from multiple sectors. TRANSPORT II will
prioritize four areas: 1) enhancement of the physical infrastructure and space which is critical for accommodating
our rapidly growing programs, 2) expansion of research training and career development programs for students
and faculty who are from underrepresented backgrounds, 3) fostering multisectoral community academic
partnerships, and 4) growing a critical mass of established social science, behavioral population health, and
implementation science researchers. Multitiered programs will include: The Community Health Advocates
Mentorship Program (CHAMPS) that combines research methods with health advocacy skills, empowering high
school students to become change agents in their communities. The Summer Program in Translational and
Community Engaged Research (SPRINTER) for undergraduate students, the Program to Accelerate Academic
Careers in Equity Research and Social Justice (PACERS) for pre-doctoral students. These programs provide a
short intensive program for students in undergraduate and graduate health professions schools, respectively.
The Transitions to Academic Careers (TRACS) will strengthen research capacity in graduate students yearlong
as they transition to the next level of their academic research careers. The TRANSPORT II infrastructure will
also expand training for post-doctoral and junior faculty and the recruitment of senior faculty. Finally, the
Community Science Cafés will provide an innovative structured venue for convening community partners from
multiple sectors and providing them with community-based participatory research and grantsmanship courses.
The collective impact of these programs will scale up the capacity for conducting transformative health equity
research at Downstate from over 100 to more than 550 trainees and community partners.

Public health relevance
NARRATIVE TRANSPORT II is aimed at expanding TRANSPORT I by enhancing the health equity research infrastructure at SUNY Downstate, recruiting and training more than 550 trainees and community partners, and developing multisectoral partnerships with key stakeholders.